Host-pathogen interactions that promote carbapenem-resistantÂ Klebsiella pneumoniaeÂ pulmonary infection

NO CHANGE FROM ORIGINAL SUBMISSION

Public health relevance
NO CHANGE FROM ORIGINAL SUBMISSION